CCBAR Workshop 2006-2007

[unreadable] DESCRIPTION (provided by applicant): The Chicago Core on Biomarkers in Population-Based Health and Aging Research will hold the 4th and 5th Annual Workshops in order to convene researchers who collect biological data in population-based studies. [unreadable] [unreadable] Specific Objectives: During attendance at the Workshops, attendees will: [unreadable] 1) Explore the applications of biophysiological measures in population-based aging and [unreadable] health research specifically aimed at: [unreadable] a. predicting health and social behavior and/or decision-making [unreadable] b. measuring past or current health and social behavior and/or decision-making [unreadable] 2) Examine how biophysiological measures of behavior and/or decision-making may change with age and life course events. [unreadable] 3) Critically consider integration of novel methodologies, including technologies and experiments, for use in population-based aging and health research. [unreadable] 4) Be availed of new opportunities for interdisciplinary and global collaboration and gain an understanding of how to address accompanying funding and logistical challenges. [unreadable] [unreadable] Design: This invited workshop is designed to appeal to an interdisciplinary audience, using multiple modes of interaction between presenters and participants for formal and informal learning, idea exchange, and relationship-building. The workshop sessions, structured over 1.5 days in the heart of downtown Chicago, include 12 hours in workshop sessions that include participant introductions, oral presentation, panel discussion, case study, and facilitated discussion. [unreadable] [unreadable] The Chicago Core on Biomarkers in Population-Based Health and Aging Research will hold the 4th and 5th Annual Workshops to bring together researchers who study heath and aging in the population by collecting data through both questionnaires and biological data collection. Focusing on innovative methods of data collection, sharing best practices, and networking for collaboration, this workshop will provide a venue for scientific presentation and discussion. By attending this workshop, researchers will increase their knowledge of biological data collection in research occurring throughout the world and further learn the usefulness and possibilities of biological data collection in population-based research; all with the purpose of advancing health and well-being. [unreadable] [unreadable] [unreadable]